Generation of suturable artificial cornea from the integration of exfoliated graphene with gelatin glycidyl methacrylate

PROJECT SUMMARY
In this project, we propose to design a hybrid scaffold from the integration of gelatin glycidyl methacrylate
(GELGYM) with exfoliated pristine graphene (EG), accompanied by double crosslinking technique, that can
function as a suturable artificial cornea. We will determine (1) whether hybrid GELGYM membranes acts as a
biocompatible artificial cornea that supports cell growth and differentiation;; and (2) the capability of the hybrid
scaffold to function as a corneal substitute. The differentiation and biocompatibility studies proposed here will
offer quantitative information on the degree of biointegration of the hybrid scaffold in contact with the host’s
corneal cells and extracellular matrix under in vitro and in vivo conditions.
We expect that exfoliation of graphene, its integration in the GELGYM hydrogel architecture and subsequent
double crosslinking can create an nano-­microspherical cavities in the hydrogel microstructure covered with the
graphene create anchoring points that can withstand against tearing, after applying the physical stress to the
suture passing the construct. This can diminish the tendency to form notches during suturing, while enhancing
mechanical properties of the construct and facilitate its implantation in patients. Moreover, we expect
integration will further promote cell proliferation and differentiation of corneal cells, allowing for the appropriate
diffusion of glucose and oxygen. Additionally, I anticipate that integration of exfoliated graphene will positively
regulate epithelial-­stromal and endothelial stromal cell interactions. The success of this approach can reduce
or eliminate the need for donor corneas and positively impact the quality of life for many patients.
The research aims are supported by a training plan focused on the acquisition of relevant multidisciplinary
expertise in the fields of cellular and molecular biology, pathophysiology, tissue-­engineering and material
science. To this end, a “Mentoring Team” which includes the leading mentor, Dr. Chodosh, along with two co-­
mentors: Dr. Gonzalez and Dr. Kong has been assembled. Moreover, Dr. Paschalis as an independent
collaborator will support on technical training on animal handling, surgery, and postoperative care along with
data analysis and interpretation of animal findings following implantation of the scaffold into rabbit eyes.
This group of mentors will guide me during the K99 mentored phase to achieve my long-­term career goal of
becoming a scientist-­leader in my field with a strong independent laboratory. I envision that this award will
provide me with an excellent platform from which to have a successful transition to independent research
faculty status (this includes the transition into the R00 phase of the award) and in the long term, to productively
compete for independent NIH (R01) funding. My training will also be complemented by courses during the
mentored phase in the improvement of presentation and writing skills (grants and manuscripts), manuscript
review, mentoring, and development of leadership abilities and laboratory management skills.

Public health relevance
PROJECT NARRATIVE Corneal transplantation currently represents the primary treatment for corneal blindness, yet severe scarcity of donor corneas in the global prospect, tissue suitability for transplantation, donor- derived infections, along with the cost of treatment and preservation are the main challenges driving the scientific community to find new solutions. In this research proposal, I aim to design a hybrid scaffold from the integration of gelatin glycidyl methacrylate (GELGYM) with exfoliated pristine graphene, accompanied by double crosslinking technique, that can function as an suturable artificial cornea. I propose a training plan that will allow me to achieve this goal from engineering techniques to biological characterization under in vitro, ex vivo and in vivo models.